Long-Term Islet Function and Impact after Total Pancreatectomy with Islet Autotransplant (LIFT)

Abstract
Total pancreatectomy with islet autotransplant (TPIAT) is performed to treat the severe, intractable pain of
chronic pancreatitis for patients who have failed medical or endoscopic therapies. The TP relieves the source
of pain, while the IAT reduces risk or severity of post-operative diabetes; after 1 year, up to 40% of patients are
off insulin and nearly 90% have islet function (C-peptide positive). However, little is known about the long-term
function of the islet graft. Rigorous studies are needed to determine what proportion of patients maintain islet
function long term and whether islet function improves glycemic control and reduces diabetes complications in
this population. This carries high potential for impact in clinical care: currently some patients are denied
coverage for IAT due to lack of rigorous studies establishing the benefit of IAT. Furthermore, we know little
about how changes in gut anatomy and associated hormones (GLP-1) and alpha cell dysregulation (glucagon)
of intraportally transplanted islets impact long-term glycemic regulation. Hypoglycemia has been increasingly
reported after TPIAT, with exaggerated incretin response and/or defective glucagon counterregulation
suggested as possible mechanisms.
We propose to study islet function, glycemic control, diabetes complications, and mechanisms impacting
glycemic control (incretin hormone axis, counterregulatory hormones) in patients who are 5-20 years out from
TPIAT. The study’s overall aim is to determine the long-term benefit of IAT. To assess islet graft function, we
will use C-peptide levels from mixed meal tolerance testing (MMTT) as the marker of endogenous islet
function. We will enroll at least 200 participants in this cross-sectional study, who are 5-20 years after TPIAT
for chronic or recurrent acute pancreatitis. The study's first aim is to determine the proportion of patients who
maintain islet graft function 5-20 years after TPIAT and to determine whether C-peptide levels from a MMTT
are associated with concurrent glycemic control measures. The second aim is to determine whether islet graft
function is inversely associated with diabetes-specific complications (severe hypoglycemia, diabetic
ketoacidosis, and micro- or macrovascular disease). The third aim is to determine other mechanisms that
impact long-term glycemic control in TPIAT, including incretin function, alpha cell function, and markers of beta
cell stress. As an exploratory aim we will recruit a subgroup of patients who are 5-20 years out from TP alone
to undergo the same testing protocol for comparison with TPIAT recipients without and with graft function. This
study's significance lies in its potential to directly impact clinical care and access to IAT when TP is needed.
We hypothesize that islet graft function improves glycemic control and reduces diabetes complications even in
recipients who are not insulin-independent, but that dysfunctional incretin and counter-regulatory responses
will impact hypoglycemia risk.

Public health relevance
Public Health Relevance Surgical removal of the pancreas with autologous transplantation of the islets (“TPIAT”) relieves the severe unrelenting pain that can result from chronic pancreatitis. The islet autotransplantation portion of the procedure reduces the need for insulin therapy early after the surgery, but little is known about the long-term diabetes outcomes in patients who have had a TPIAT. In this study, we will evaluate how well islets function 5- 20 years after an islet autotransplant, what factors and hormones are important in regulating blood glucose [preventing high and low blood glucose], and whether diabetes complications are reduced by having functioning islets.